Reducing Challenging Behaviors In Children With Autism Through Digital Health

PROJECT SUMMARY
The project will develop and pilot test a personalized medicine mobile health application, KeepCalm, that
incorporates physiological stress measurement to support evidence-based practices for reducing challenging
behavior in children on the autism spectrum. As much as 80% of children on the autism spectrum exhibit
challenging behaviors that can have a devastating impact on personal and family well-being, contribute to
teacher burnout and require frequent hospitalization. Evidence-based practices for reducing these behaviors
emphasize uncovering triggers, yet parents and teachers often report that challenging behaviors surface without
warning. Challenging behaviors caused by emotion dysregulation can be the most difficult to predict, as children
on the autism spectrum often have difficulty communicating their distress before it results in challenging behavior.
Exciting recent advances in digital technology now allow measurement of momentary emotion dysregulation,
using physiological indices. Our pilot data from four separate samples demonstrate that increased heart rate
predicts onset of challenging behavior in children on the autism spectrum. In order to tailor KeepCalm to end
users and avoid potential barriers to its adoption, in Aim 1, we will evaluate the acceptability, feasibility, and
appropriateness of app, and the needs of educational teams in managing stress in children on the autism
spectrum and challenging behaviors, by conducting interviews with teachers of children on the autism spectrum,
parents of children on the autism spectrum and school administrators, and conducting structured in-class
observations with teachers. Through the activities of Aim 2, we will improve KeepCalm, building on our initial
app prototype, in collaboration with our established technology partner, Alevio, and our established community
partner, the School District of Philadelphia. We will do this through 1) exploratory work on the specificity of heart
rate increase to challenging behavior, on app clinical decision support timing, and on the association of app false
positives and negatives to movement or child factors; 2) monthly advisory board meetings with expert
stakeholders for app development guidance, and; 3) rapid-cycle prototyping of the app with 10 educational teams
(i.e. 1-2 children on the autism spectrum, and their teacher and classroom aide, if they have one). This will allow
for iterative improvement based on each user’s experience. Through Aim 3, we will test the app for usability,
acceptability, feasibility and appropriateness, as well as preliminary effectiveness with 20 educational teams in
a randomized waitlist field trial over a 3-month period. Successful completion of these aims will result in a novel
m-health app designed to help teachers support emotion regulation, and reduce or prevent challenging behavior
in children on the autism spectrum, using evidence-based strategies. These activities will lay the foundation for
an R01 to evaluate the effectiveness of KeepCalm in a full-scale randomized field trial. Our proposal aligns with
the strategic plan of the Interagency Autism Coordinating Committee, to maximize the potential for technology-
based interventions to improve the lives of people on the autism spectrum.

Public health relevance
PROJECT NARRATIVE School-based behavioral approaches to managing challenging behaviors in children on the autism spectrum are limited by three key factors: 1) children on the autism spectrum often have difficulties communicating their emotions; 2) it is challenging to implement evidence-based, personalized strategies for individual children, and; 3) it is difficult for teachers to track which strategies are successful for individual children. Our proposed personalized mobile-health emotion regulation application will pair heart rate tracking with digital tools to help reduce challenging behavior by supporting stress detection, reminding teachers of specific behavioral strategies and helping teachers to track progress.